MBRS Support of Continuous Research Excellence at Brooklyn College

[unreadable] DESCRIPTION (provided by applicant): Brooklyn College of the City University of New York is a large, diverse urban campus with just under 50% minority students. The college has an enrollment of ~11,000 undergraduates and ~4,500 master's students. We also participate in doctoral training with highly regarded on-campus doctoral programs in the sciences as part of the Graduate Center of CUNY. The College values teaching and has a strong record of sending a diverse group of students on for research doctorates. Our faculty members mentor several hundred students a year, including many underrepresented minority students, in laboratory-based research. The College has designated 3 biomedical research faculty to take part in this supplemental application. The project will allow SCORE participants to increase their research capabilities and productivity and to contribute fully to strengthening the institution's research culture and reputation. [unreadable] [unreadable] The overall goals of the project are: (1) to increase SCORE faculty research productivity by adding to the number of postdoctoral fellows, graduate students and undergraduate students working in SCORE-supported research labs; by increasing the research infrastructure by adding key laboratory equipment, a bioinformatics/ modeling facility and replacing an old and unreliable cage washer; and fostering increased collaboration with investigators with both Brooklyn College faculty and with external scientists; (2) to increase research competitiveness of SCORE faculty by increasing the number of refereed publications submitted and published, of presentations given at national conferences, and of external grant submissions and awards; by bringing a number of prominent scientists to campus to present their work and discuss research issues with SCORE faculty; and by providing faculty development workshops on skills that successful research scientists need to master to be productive and successful as they balance research, teaching, mentoring, publishing, and service to the college community; (3) to increase the number of minority faculty at the College involved in biomedical research by developing a detailed and proactive plan for diversity science hiring efforts in conjunction with our administration, our departmental hiring committees, and an external advisory committee. The College President has agreed to set a target of hiring one minority science faculty member a year for the four years of the SCORE project. [unreadable] [unreadable] [unreadable]